SRI INTERNATIONAL:1110101 [19-010371]

Continuous Rodent and Non-Rodent Pharmacokinetic Assessments for pain research

“This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”